Massachusetts Lab Food Safety Testing Program

Overall Project Summary/Abstract
The Massachusetts State Public Health Laboratory (MA SPHL) is requesting funding under RFA-
FD-25-007, Laboratory Flexible Funding Model (U19) to enhance human and animal food
surveillance through risk-based and prevention-focused testing. MA SPHL intends to partner with
MA Department of Agricultural Resources (MDAR) for sample collection. MA SPHL currently has
six testing methods accredited by A2LA to the ISO 17025 standard: screening and confirmation
methods for Listeria monocytogenes, E. coli O157:H7 and Salmonella spp. Funds will be used to
support current ISO 17025 accredited method capability and bring additional methods on ISO
scope to increase capability. MA SPHL is seeking approval for the following Microbiology
Analytical Tracks:
• A1: Human Food Product Testing. MDAR has agreed to collect a minimum of 100
environmental swabs from human food production sites, which will be tested for multiple
foodborne pathogens, resulting in 250 analyses.
• A3: Animal Food Product testing. MDAR has agreed to collect 50 animal food products
per year, both domestic and production feed, which will be tested for multiple pathogens
and result in 100 analyses.
• A4: Whole Genome Sequencing (Maintenance). All recovered isolates will be
sequenced, analyzed and uploaded to the appropriate national databases or repositories
in accordance with PulseNet/GenomeTrakr procedures and will include required metadata
that is formatted in a manner that supports querying NCBI.
• A7: Method Development/Validation. MA SPHL intends to participate in future method
development and capacity/capability development projects pre-determined by FDA that
support and expand food safety and food defense testing in years 2 through 5.
• A8: Microbiology Capability/Capacity Development. MA SPHL intends to participate
in future capability/capacity development projects to assist laboratories in implementing
new capabilities (e.g., methods, equipment) to support microbiological testing related to
human and animal foods in years 2 through 5.

Public health relevance
Project Narrative: The Massachusetts State Public Health Laboratory (MA SPHL) intends to enhance its human and animal food surveillance systems by focusing on risk-based and prevention-focused testing via collaboration with the Massachusetts Department of Agricultural Resources (MDAR) for sample collection. This partnership and the resultant data will ultimately contribute to strengthening the overall national food safety system.